Tumor stromal effects of DDR2 in metastasis regulation

PROJECT SUMMARY
It is now appreciated that the tumor microenvironment contributes to tumor cell spread and response to
therapy. The tumor environment (or stroma) consists of non-tumor cells, structural proteins, and embedded
growth factor and cytokines, and in breast tumors these components differ from their normal tissue
counterparts in composition, architecture, and function. A major challenge then to the prevention and
treatment of breast cancer metastasis is to understand how the tumor environment influences tumor cell
invasive/migratory capacity. We have identified a novel collagen I stimulated DDR2 (a RTK) signaling pathway
that is active in both tumor cells and tumor stromal cells and a critical regulator of breast cancer metastasis.
We have genetically validated DDR2 as a novel and viable therapeutic target for prevention and treatment of
metastatic disease. Because of its actions, inhibition of DDR2 activity in tumors should affect both tumor cells,
tumor stroma and the communication between tumors and their environment.
In tumor cells, we have shown that DDR2 controls collective migration/invasion through the collagen-
rich tumor ECM to access blood vessels. In new work we have found that the action of DDR2 in the tumor
stroma controls ECM production, collagen fiber organization, and angiogenesis, yet we do not know in which
cells within the tumor stroma DDR2 is important for these effects and how. Furthermore, we have found that
DDR2 exhibits distinct kinase-dependent and kinase-independent cellular effects that could pose challenges to
therapies directed only at inhibiting kinase activity. Since the action of DDR2 within cells of the primary tumor
stroma is important for metastasis, this proposal is focused on determining its function(s) in the tumor stroma.
There are three specific aims. In the first aim we will determine in which tumor stroma cells the action of DDR2
contributes to changes to tumor fibrosis and collagen organization, and how. Second, we will determine
whether the endothelial cell intrinsic action of DDR2 contribute to the breast tumor angiogenesis and how.
Finally, in the third aim we will determine the in vivo consequences for metastasis and mechanism(s) of action
of kinase-independent and kinase-dependent DDR2 in breast tumor cells and breast tumor CAFs.

Public health relevance
PROJECT NARRATIVE The majority of breast cancer deaths result from metastatic disease. Recent work has identified changes within the tumor microenvironment as being critical for tumor progression, metastasis, and response to therapies. During tumor progression the structure of the tumor stromal is remodeled and these changes facilitate tumor cell invasion, yet how is not fully understood but clearly important to determine if we are to effectively intervene therapeutically. This is a proposal to determine how the tumor stroma is modified during tumor progression and its impact upon metastasis.